Research Education Core

ABSTRACT
The overall goal of the Yale ADRC Research Education Component (REC) is to recruit and promote the careers
of a cohort of junior investigators from a diverse scientific and cultural backgrounds that will pursue rigorous,
innovative and high impact biological, translational, and clinical research and will become future leaders in the
Alzheimer’s disease and related dementia fields. Our application builds upon a successful track record of Yale
and the ADRC in promoting the careers of junior investigators with broad interest in research relevant to the
dementia field. To achieve our goals, the REC will closely interact and coordinate educational activities with all
other ADRC Resource cores including the community outreach core. Furthermore, in order to encourage
investigators to explore the mechanistic heterogeneity of dementia including systemic and aging factors, we will
closely link our REC educational and networking activities with those of the Yale Older Americans Independence
Pepper Center. The ADRC REC will provide personalized mentorship programs and comprehensive and
interdisciplinary didactic activities and courses addressing key research, leadership, teaching and grant writing
skills. In addition, the REC will provide various levels of financial support commensurate with the investigators
career stage and will offer relevant technical training and priority access to all ADRC research cores. To recruit
an expanded group of investigators, including junior faculty, clinical/research fellows and graduate students, we
will have three categories of REC investigators: ADRC Scholars will receive financial support to protect their
research time and will have priority access to the Center Cores; Small REC Awardees will receive support for
pilot work that will allow them to apply for future ADRC Scholar funding; REC Affiliates will have access to all the
resources of the ADRC and participate in didactic, career development and academic activities. Overall, the
newly organized REC will serve as a hub for all educational, didactic and career development activities aimed at
promoting the development of future leaders that will bridge clinical and basic sciences to improve clinical
outcomes and quality of life of individuals with dementing disorders.

Public health relevance
PROJECT NARRATIVE: Per the program announcement, the Cumulative Project Narrative has been included in the Overall Component, Other Project Information section.